Selective Targeting of Nicotinic Acetylcholine Receptor Subtypes for Cocaine Use Disorder

ABSTRACT
The number of overdose deaths caused by stimulants like cocaine and methamphetamine has increased at an
alarming rate over the last decade. Yet, unlike other addictive substances, such as alcohol, nicotine, and opioids,
there are currently no FDA-approved medications for stimulant use disorders, leaving millions of Americans
without an effective therapeutic treatment. Growing evidence indicates that the α3β4 subtype of the nicotinic
acetylcholine receptors (nAChRs) play an integral role in drug addiction and that selective inhibition of these
receptors reduces the addictive properties of cocaine, methamphetamine, and other drugs of abuse. However,
existing classes of α3β4 nAChR antagonists suffer from poor selectivity, are not brain-penetrant, or induce partial
activation of the receptor, which hinder their clinical development. The objective of this proposal is to develop a
novel class of α3β4-selective nAChR negative allosteric modulators (NAMs) based on the alkaloid aristoquinoline
and demonstrate their effects in animal models of cocaine use disorder. Preliminary data generated in our lab
indicate that aristoquinoline and its derivatives potently and selectively inhibit α3β4 nAChR activation and
significantly reduce drug-seeking behavior in an animal model of cocaine relapse. The proposed studies will
build upon these results by testing the central hypothesis that α3β4 nAChRs NAMs based on the aristoquinoline
scaffold can safely and effectively reduce the addictive properties of cocaine. Aim 1 will optimize the α3β4
potency and selectivity of aristoquinoline by generating a collection of rationally designed derivatives and
evaluating their affinity and functional activity. Aim 2 will locate the aristoquinoline allosteric binding site, define
the mechanism of action, and identify off-target liabilities. Aim 3 will translate these results in vivo by prioritizing
lead compounds with optimized drug-like properties and advancing them into preclinical safety studies and
efficacy models of cocaine self-administration and relapse. This research is innovative, as it seeks to address
and overcome the limitations of existing α3β4 antagonists by investigating an understudied class of nAChR
ligands with a unique mechanism of action. The results from these studies will be significant because they will
produce the ideal pharmacological probe for investigating the function α3β4 nAChRs in vivo and deliver
promising drug leads for the treatment of cocaine use disorder.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it seeks to develop α3β4-selective nicotinic acetylcholine receptor (nAChRs) negative allosteric modulators as novel pharmacotherapies for cocaine use disorder. Because the α3β4 nAChRs have been implicated in the addictive properties of nearly all drugs of abuse, these antagonists have the potential to have a significant and far-reaching impact on the treatment of drug addictions. Thus, this research is relevant to the National Institute on Drug Abuse’s strategic goal to “develop new and improved treatments to help people with substance use disorders achieve and maintain a meaningful and sustained recovery.”